Comprehensive Assessment of Delirium Risk due to Medications

ABSTRACT
Delirium, or acute confusional state, affects 30-40% of hospitalized older adults, with the added cost of care es-
timated to be up to $7 billion. Medications are one of the most common causes of delirium and potentially one
of the most preventable and most treatable, with medications thought to be the sole precipitant for delirium in
up to 39% of cases. Despite the critical role of medications as a source of delirium, surprisingly few studies have
investigated this topic, often focused on only a few medications and with only modest quality. In this proposal, we
will address these limitations by utilizing data collected through our Virtual Acute Care for Elders (ACE) quality
improvement project, which instituted delirium screening once per shift by nursing staff for all individuals over
age 65 admitted to University of Alabama at Birmingham (UAB) Hospital for the past decade. This unprecedented
volume of data on more than 81,000 patients will allow us to achieve the necessary sample sizes for effective ap-
plication of data mining algorithms. Data mining algorithms that discover patterns of associations in data, rather
than testing predetermined hypotheses, are well suited to application in large-scale algorithms to identify med-
ications associated with increased odds of delirium. Combining data mining with our Virtual ACE and hospital
electronic health record (EHR) data, we will be able to evaluate more than 1,000 individual medications, as well
as medication combinations and medication classes, for their association with delirium. Such a comprehensive,
data-driven examination of delirium due to medications will be a significant contribution to our understanding of
the risk factors and management of delirium in the older adult population.

Public health relevance
PROJECT NARRATIVE Delirium, or acute confusional state, affects up to 7 million hospitalized older adults annually and is associated with long-term declines in cognition and function. Medications are thought to be the cause of up to 36% of delir- ium and be contributory to an even higher percentage but are surprisingly understudied, with studies to date focusing on only a few medications and being only modest quality. In this secondary data analysis, we will apply machine learning data mining methods to a large electronic health record database with a decade of delirium as- sessments to comprehensively examine the risk of delirium due to medications, which in turn will lead to improved management for this serious but often overlooked disorder.